IBD Gene Mapping by Clinical and Population Subset

PROJECT SUMMARY
Inflammatory bowel disease (IBD), Crohn’s disease (CD) and ulcerative colitis (UC) are complex genetic
disorders of the gastrointestinal tract, and a major health burden to patients and society. Multicenter
collaborative studies from 6 Genetics Research Centers (GRCs), organized with a Data Coordinating Center
(DCC) to form the NIDDK IBD Genetics Consortium (IBDGC) has contributed to tremendous progress in
dissecting IBD genetic etiology with identification of over 200 IBD loci by genome wide association studies
(GWAS). Our GRC has contributed to all IBDGC studies and has taken roles in IBDGC leadership positions.
Our particular GRC focus is uncovering and characterizing the genetic etiology of IBD, and variations in
phenotypic expressivity and disease course, in the African-American population. We will continue to recruit
and carefully phenotype African-American patients with IBD to maximize power for genetic and phenotype
investigations. We will also recruit patients for parallel IBDGC focused studies in the Hispanic/LatinX
population. We will expand and refine IBD loci contributing to the genetic risk of IBD in African-Americans by
further GWAS, with sex-stratified, and fine-mapping approaches, and evaluate genotype-phenotype
associations. We will perform a multiple immune disease association meta-analyses aggregating genome-
wide data to maximize power to identify common immune mediated disease loci while also characterizing
pleiotropy among the traits evaluated. We will provide critical resources in immune cells isolated from West-
Africans and African-Americans and generate gene expression and epigenetic data for colocalization to
better define disease causing variants and their effect on gene expression that result in the genetic risks of
IBD in the African-American population. Lastly we will continue to participate in all IBDGC activities to
maximize the impact of IBD genetics research by this cooperative funding mechanism.

Public health relevance
PROJECT NARRATIVE According to the Center for Disease Control and Prevention, an estimated 1.4 million Americans suffer from Inflammatory Bowel Disease (IBD), a chronic debilitating disorder that includes Crohn’s disease and ulcerative colitis. IBD ranks in the top 5 in prevalence for gastrointestinal disorders and represents a significant financial burden to society requiring a lifetime of medical care as there is no cure for this disease. This proposed research aims to determine the genetic variations that cause IBD which will aid in developing preventive measures, improving the quality of care with better treatment plans and educating patients through genetic counseling.